Core 1

Core 1 - Research & Development Contemporary biomedical and behavioral sciences require sophisticated computation. In Core 1, a team of quantitative scientists (information and computer scientists, biostatisticians, mathematicians, and software engineers) will develop the software infrastructure (i.e. the BCl core), services, and tools for use by biomedical and behavioral researchers. An illustration of major components is shown in Figure B-1. Current state of the art research infrastructures containing biomedical data warehouses essentially have three levels of data disclosure: (1) query results counts, (2) de-identified data, and (3) identified data. Deidentification and anonymization are related, but different concepts. While de-identification consists of removal of particular identifiers, anonymization provides a means for data not be traced back to one particular individual. Simplistic measures (Murphy SN & Chueh HC 2002) are cun-ently applied to step (1) above to prevent the tracing of information to a particular individual using the results of several query counts, and previous research indicates that the de-identification of data disclosed at level (2) is not sufficient to preserve individual privacy (Sweeney 1997). Therefore, at both levels (1) and (2) robust anonymization algorithms are necessary. Formal proofs for adherence to quantitative privacy criteria are hard to produce, and consequently only available for a few methods in limited settings (Lasko 2007). As a consequence, most approaches in use today have not been rigorously validated theoretically or with real data. The three levels of disclosure outlined above are insufficient for responsible data sharing beyond the scope of an institutional IRB (in a HIPAA covered entity) such as a federated data warehouse to which multiple institutions or sources can contribute data. For this and other reasons, institutional clinical data repositories for research, some of which receive federal funding for their creation and/or maintenance, have been restricted to researchers who are formally affiliated with the institution. To address this limitation and progress towards a stage in which data can be shared across institutions, we propose research into: (a) a tool that interfaces between clinical data and a user, and that can answer limited queries while ensuring that privacy is preserved, (b) a tool that can simulate real data in a privacy preserving manner to the point that the simulated data can be used as a proxy in population based analyses, and (c) a cryptographic data submission protocol that hides the identity of the submitting entity.